Early Pathogenic Steps in Xenobiotic-Induced Autoimmunity

Autoimmunity is thought to result from a combination of genetics, environmental triggers, and stochastic events.
A characteristic of systemic autoimmune diseases, like systemic lupus erythematosus (SLE), are autoantibodies
against nuclear antigens (ANA), however the events that initiate such autoantibody responses remain poorly
understood. This is due largely to an incomplete understanding of when and how autoimmunity begins in humans
and animals models of spontaneous autoimmunity. However, certain environmental/xenobiotic exposures have
been linked to autoimmunity in humans and reproduced in experimental animal models, thus providing model
systems where the initiating event and its exposure site are known. These induced models of autoimmunity
provide a unique opportunity for dissecting the immunological response specific to known inciting agents and
are significantly more amenable to identifying the early events necessary for autoimmunity that are difficult to
study in spontaneous autoimmune diseases. We propose to exploit this feature in order to study the early
molecular and cellular events leading to loss of B cell tolerance and autoantibody production. Mercury exposure
in humans is linked with pathological outcomes including inflammatory markers, autoantibodies and renal
pathology. These observation have been faithfully reproduced in experimental animal models. Importantly,
murine mercury-induced autoimmunity (mHgIA) induces an MHC-restricted autoantibody response against the
nucleolar protein fibrillarin which is also found in patients with SLE and Scleroderma. We believe that elucidation
of the mercury-induced anti-fibrillarin response will provide insight into the early events necessary for the creation
and expansion of autoreactive B cells, a cardinal feature of the autoimmune response. We propose three aims
that will define different, but related, events in the secondary lymphoid organs that result in loss of tolerance and
autoantibody production following mercury exposure. Aim 1 will define the early immunological steps in
xenobiotic-induced autoimmunity, and characterize the immunopathologic changes in the draining lymph nodes
(LNs), spleen and bone marrow following single and multiple subcutaneous exposures to mercury. In Aim 2 we
will determine what factors are critical for the development of activated CD4 T cells, autoimmune GCs, and
autoAbs in the early stages of mHgIA. Proposed experiments will determine how the deficiencies of several key
genes required for T-dependent immune responses in SLE or mHgIA (Unc93b1, Tlr7, Il6, and Ifng) affect the
early and autoimmune secondary lymphoid organ responses to HgCl2. Finally, Aim 3 studies will determine the
Hg-induced autoreactive B cell repertoire by characterizing the evolving B cell antigen receptor repertoire
induced by mercury exposure in secondary lymphoid organs. When completed these studies will lead to a greater
understanding of the early molecular and cellular events leading to development of autoantibody production.

Public health relevance
Narrative The presence of autoantibodies in the blood are an important indicator of autoimmune diseases, including those associated with exposure to toxic materials like mercury. An animal model of mercury-induced autoimmune disease will be used to determine the early steps in autoantibody production. These studies will lead to a greater understanding of the development of autoimmune disease.